Molecular dynamics studies of K+ and Na+ channels and biomembranes based on a polarizable force field

Project Summary
My group seeks to understand, at a fundamental level, the function of voltage-gated potassium (Kv) and sodium
(Nav) channels using molecular dynamics (MD) simulations based on atomic models. Despite the enormous
progress in structure determination, our comprehension of ion permeation, selectivity, activation, inactivation and
regulation remains incomplete. It is also crucial to keep in mind that a biological membrane is much more than
a simple passive and featureless environment, but a complex dynamical molecular supra-assembly. The activity
of ion channels is affected by a hosts of factors associated with the membrane, often modulated by ion-mediated
electrostatic interactions. Lipids are also directly involved in the activation of specific channels and signaling. MD
simulations based on atomic models can play an important role in understanding the fundamental physical forces
driving the structure and dynamics of these complex biomolecular systems. Using MD, we will study mechanism
of selective ion permeation (knock-on v.s. hard-knock) and the molecular basis of voltage-activation as well as
C-type inactivation. The latter will examine the classic inactivating W434F Shaker K+ channel mutant based on
recent structural information from cryo-EM and X-ray crystallography. On the experimental side, we continue to
investigate the factors affecting the activation and inactivation of K+ channels using cryo-EM and X-ray
crystallography. We will also expand the scope of our research by examining the function of Nav channels,
including selectivity, permeation, activation, and inactivation.
To obtain meaningful computational results from MD simulations, it is crucial to accurately model the
physical forces associated with changes in the electronic distribution, a need that has stimulated the
development of polarizable models going back many decades. Our efforts have focused on developing a
polarizable force field (FF) in the context of the classical Drude oscillator model. The Drude model covers many
molecular components and has been implemented in many simulation programs (CHARMM, NAMD, GROMACS,
OPENMM, and the CHEMSHELL QM/MM software). However, there is a critical need to expand the type of
phospholipids covered to enable the modeling of a broader range of biomembrane processes. We will develop
the FF for the most important charged lipids like phosphatidylserine (PS) and phosphatidylglycerol (PG), and
explore the biology of phosphatidylinositol-4,5-bisphosphate (PIP2). Calculations of the permeability coefficient
of small molecules will be used to validate the optimized FF. We will also undertake several technical
developments on the propagation of the Drude model, enhanced sampling, conformational sampling, and
machine learning algorithms, etc. The planned simulation studies based on an accurate and computationally
efficient polarizable FF promise new fundamental insight into the function of ion channels and a host of
biomembrane phenomena.
1

Public health relevance
Project Narrative The goal of my research is to deepen our fundamental molecular level understanding of all aspects of the function of K+ and Na+ channels and biomembranes using molecular dynamics (MD) simulations based on atomic models. Malfunction of ion channels have a broad impact on human health, including neurological disorders, epilepsy, heart arrhythmia, immune response, and cellular secretion. The fundamental knowledge gained by the proposed studies promises new insight that will support the development of molecular therapies targeting these channels.